DNA Methylation Markers, Genes and Breast Cancer Risk

PROJECT SUMMARY
Genome-wide association studies (GWAS) have identified common variants in ~200 genetic loci associated
with breast cancer risk. However, it is difficult to translate these findings to disease prevention and treatment
because causal genes and underlying mechanisms in these loci are largely unknown. Increasing evidence
suggests that epigenetic regulation may be on the causal pathway between genetic variants and diseases.
DNA methylation, one of the most frequent and important epigenetic modifications, plays a crucial role in
cancer development. However, it is almost impossible to collect pre-diagnostic breast tissues to profile the
methylome from a large number of participants. Herein, we propose a novel -omics approach: a methylation-
wide association study (MeWAS) using genetic instruments. In Aim 1, we will build race-specific prediction
models using genome wide methylation and genetic data in fresh-frozen breast samples from 600 cancer-free
women of African-, Asian- and European- ancestry (200 per race). These models will then be applied to the
GWAS data from three large consortia, including ~123,000 cases and ~106,000 controls of European, ~25,000
cases and ~25,000 controls of Asian-, ~20,000 cases and ~20,000 controls of African- ancestry to impute
methylation levels. The genetically predicted methylation levels will be tested in association with breast cancer
overall and by estrogen receptor and HER2 status. In Aim 2, we will perform a series of integrative functional
analyses to evaluate the functions of promising methylation sites and the potential target genes regulated by
these methylation sites. In Aim 3, we will select the top 20 methylation sites and their target genes for in vitro
functional assays to assess their influence on major cell functions related to cancer biology. Given the strong
pilot data, unique resources from three large genetic consortia, and our team's extensive expertise and
experience, we are uniquely positioned to conduct this project. The findings will greatly improve our
understanding of the genetic and biological basis of breast cancer pathogenesis and facilitate the translation of
genetic findings to prevention and treatment.

Public health relevance
NARRATIVE We propose to conduct a well-powered multi-omics study to discover novel methylation markers and novel genes for breast cancer risk in three racial groups. Findings from our association study, together with integrative bioinformatics and functional experiments, will greatly improve our understanding of novel mechanisms for genetic effects on breast cancer. The identified methylation markers could be used in risk-assessment and risk-stratifying for the prevention of breast cancer.